Admin Core

SUMMARY
The overarching goal of this P01 project is to develop a broadly effective vaccine to stop HCV
transmission. The Admin Core is responsible for overseeing and supporting the research
activities to accomplish four broad areas: Administrative and Fiscal Management,
Communication Management, Scientific Oversight, Scientific Outreach. The Admin Core will be
led by the P01 Program Director with the help of an Admin Core Manager to accomplish the
following tasks: (i) fiscal oversight of the different research sites; (ii) facilitation of communication
and reagent sharing between research labs; (iii) coordination of sample shipment and storage
between the research sites; (iv) monitoring scientific progress through internal reviews and the
annual scientific advisory board meeting; (v) assistance of researchers in the preparation and
submission of scientific publications.